NINDS TOXICOLOGY CONSULTING SERVICES (NIH BPN, NIH HEAL AND OTHER NIH NEUROSCIENCE-FOCUSED DRUG DISCOVERY AND DEVELOPMENT PROGRAMS)

Toxicology SME(s)
Toxicology SME consultants will be expected to provide senior-level expertise and contribute feedback and guidance on projects to the NIH and to LDT members through conference calls and by email. The role of the consultants may include but are not limited to the following responsibilities and tasks:

a) Help establish toxicology endpoints and milestones for a project, recommend bioassays to be incorporated into a testing funnel or development plan, design toxicology and pharmacology studies, and interpret data delivered by CROs.

b) In partnership with other consultants, contractors, and the NIH staff, advise, strategically plan, and manage programs to facilitate lead optimization, IND enabling, and clinical studies

c) Serve as a resource to the LDT for toxicology requirements, pharmacology and logistics to conduct biologics development activities for biologics from the preclinical stage through to the initial clinical stage

d) Serve as the toxicology expert in order to identify potential developmental challenges and suggest strategies to address these challenges

e) Collaborate on design of investigative toxicology studies in support of biologics development

f) Review toxicology sections of regulatory filings provided by CROs or PIs

g) Collaborate on the design of investigative studies in support of biologics development.

h) Provide expert support of preclinical strategy development including that for neurological diseases

i) Support in vitro and in vivo model development for neurological disease

j) Support design and interpretation of in silico analyses and in vitro/ ex vivo
screening strategies for oligonucleotides

k) Support of design PK/PD and toxicology safety studies

Public health relevance
Subject matter expert support for developing therapies for neurological disorders